The Underlying Biology of Health Disparities

The biological and behavioral health disparities research focuses on the HANDLS study. Our work this period has focused on biological aging and weathering, frailty, biomarkers of aging, mortality, and inflammation. For example, one of our interesting projects used a new DNA methylation biomarker, Dunedin Pace of Aging Calculated from the Epigenome (DunedinPACE), is associated with healthy lifespan in several European ancestry cohorts. Few studies have examined the relation between dietary quality and DunedinPACE in African American and White adults with longitudinal assessments. To assess the relationship between diet quality and DunedinPACE, we used longitudinal data from African American and White 30–64-year-old adults living above and below poverty. Participants' DunedinPACE scores and dietary assessments were calculated at two time points, approximately 5 years apart. Numbers of participants (n = 421; mean age 49 years) were balanced by race, sex, and poverty status. Diet quality was assessed using two different dietary indexes: Dietary Inflammatory Index (DII) and Healthy Eating Index-2010 (HEI). Linear mixed model regression examined the longitudinal association of DunedinPACE with DII and HEI adjusted by age, race, poverty status, BMI, and smoking status. Initial mean values of DII were 3.34 (SD = 2.16) and HEI was 40.67 (SD = 11.69), indicating a pro-inflammatory dietary pattern and low diet quality in this cohort. The initial mean DunedinPACE score was 1.07. We found that a higher DII score was associated with a higher DunedinPACE score (β = 0.009; p < 0.001), higher HEI score was associated with lower DunedinPACE score (β = - 0.001; p = 0.032), and that these relationships were consistent over time. Overall, lower dietary quality was associated with a faster pace of aging captured by DunedinPACE score. Our findings demonstrate the independent contribution of diet quality to healthy aging-related epigenetic mechanisms. Suggesting that diet quality is an important target for intervention studies to slow biologic age acceleration.